Cell Mediated Renal Injury In Lupus

Macrophages (M0) are integral in the pathogenesis of renal disease. Activated M0 induce apoptosis in resident renal cells. M0 rich infiltrates are characteristic of renal disease in the MRL-Fas'pr strain with features that are similar to human lupus. Autoimmunerenal disease in MKL-Fasipr mice is spontaneous, rapid and lethal, and is accompanied by a profound systemic illness. Thus, identifying molecules that regulate M0 numbers and functions in MRL-Faslpr kidneys is central to the pathogenesis of nephritis. Colony Stimulating Factor 1 (CSF-1) is a primary regulator of the M0, responsible for survival, differentiation, and proliferation. There are three distinct CSF-1 isoforms; a cell surface glycoprotein, and two secreted isoforms; a glycoprotein and proteoglycan. Studies in transgenic mice that each only express an individual CSF-1 isoform indicates that there are distinct functions for each CSF-1 isoform during normal development. In light of the importance of CSF-1 in M0 mediated renal disease, it is critical to identify the local sites of CSF- 1 synthesis, and functions of these CSF-1isoforms during lupus nephritis. The actions of CSF-1are exclusively mediated via the CSF-1 receptor (CSF-1R), principally on mononuclear phagocytes. However, CSF-IRs are on intrinsic renal cells, the tubularepithelialcell (TEC). Since TECs are a major source of CSF- 1 during renal inflammation, we suggest that CSF-1 mediated TEC mechanisms are pivotal in the pathogenesis of autoimmune renal disease. We hypothesize that CSF-1 isoforms have shared and unique roles in the pathogenesis of lupus nephritis. To test this hypothesis we propose to use novel genetically constructed mouse strains. The specific aims are: 1) To determine whether CSF-1, and certain individual CSF-1 isoforms, promote lupus nephritis, and the systemic illness in MRL-Fas''"' mice; and 2) To determine the role and location (renal, non-renal) of CSF-1, individual CSF-1isoforms, and the CSF-lR's in the pathogenesis of lupus nephritis, and the systemic illness in MRL-Fas''"" mice. Taken together, the proposed experiments will identify the potential role of CSF-1 isoforms in the pathogenesis of human lupus nephritis and the systemic illness.